Systems modeling of shared and distinct molecular mechanisms underlying comorbid Major Depressive Disorder and Alzheimer's disease

Comorbidity of Alzheimer's disease (AD) and Major Depressive Disorder (MDD) is frequent but unexplained by
common genetic variants. Members of the Accelerating Medicines Partnership-Alzheimer's Disease (AMP-AD)
program have exhaustively profiled gene expression in multiple brain regions from AD and control subjects
through multiple cohorts and then performed systems biology analyses to identify molecular networks and
drivers implicated in late onset AD. VGF (non-acronymic) is one of the top ranked AD drivers conserved in
multiple cohorts. We show that VGF overexpression in hippocampus reduces neuropathology and cognitive
impairment in the 5xFAD mouse model of amyloidosis (Beckmann et al., under review), and VGF is already
known to have a role in depression. Its AD network includes the dual-specificity phosphatases DUSP4 and
DUSP6 (MAP Kinase Phosphatases 2 and 3, respectively), all reduced in level in AD, connected via their
network to Amyloid Precursor Protein/Abeta and Tau, and also previously identified by our group to be part of a
network that contributes to MDD in females only. Our published and preliminary studies further demonstrate
that VGF levels are reduced in MDD, in hippocampus and PFC, and that VGF overexpression in these regions
has antidepressant efficacy in mice. Preliminary network analysis further identifies (1) an immune module with
colony stimulating factor 1 receptor (CSF1R), a protein required for adult microglial survival, as a driver down-
regulated in AD plus MDD, but up-regulated in AD alone, and (2) aquaporin-4 (AQP4), a brain water channel,
which is down-regulated in AD plus MDD vs AD, is expressed in astroglial endfeet, and is implicated in AD.
We hypothesize that members of our identified VGF, CSF1R, and AQP4 causal networks contribute to
cognitive decline, depression-like behavior, and neuropathology in mouse models and patients with AD and
MDD. In Aim 1, high throughput transcriptomics, proteomics, and multiscale network molecular modeling will
be carried out on dorsolateral prefrontal cortex (DLPFC) from a new cohort of AD patients with and without
comorbid MDD, MDD patients without AD, and control subjects, to identify additional shared and distinct
molecular mechanisms that regulate these two diseases. In Aim 2, we propose to determine the role(s) that
the VGF/DUSP shared network plays in comorbid MDD plus AD, by determining the underlying pathways by
which VGF, DUSP4, and DUSP6 block or delay cognitive dysfunction, depression-like behavior, and the
development of neuropathology, including microglial changes, utilizing AAV-mediated overexpression
strategies in APP/PS1 mice. In Aim 3, we will validate the novel subnetworks and key drivers identified in Aim
1 that differentiate AD plus MDD from AD alone. Initially, we will investigate CSF1R/immune/microglial and
AQP4/astroglial network function in depression-like behavior, neuropathology, and the regulation of gene
expression (transcriptomics), in APP/PS1 mice overexpressing either CSF1R or AQP4, and also for CSF1R, in
APP/PS1 mice that lack TYROBP, resulting in a normalized immune module and rescued cognitive impairment.

Public health relevance
Narrative Alzheimer's disease (AD) and Major Depressive Disorder (MDD) both have devastating public health impacts. and although comorbidity is common, it is not explained by common genetic variants. We will utilize high-throughput genomics and proteomics to identify shared and unique molecular pathways that regulate the pathogenesis of comorbid AD and MDD. Validation studies in mouse models of AD and depression-like behavior will investigate the roles of components of these newly discovered networks, identifying similarities and differences between AD alone and AD with comorbid MDD, with initial focus on the function of a recently identified VGF-containing network that contributes to both MDD and AD.